Real-world impact of the COVID-19 pandemic in people with multiple sclerosis

PROJECT SUMMARY AND ABSTRACT.
The COVID-19 pandemic due to the SARS-CoV-2 infection poses new challenges to the ~3 million persons
with multiple sclerosis (PwMS) worldwide. Major knowledge gaps include the extent to which common MS
disease modifying therapies (DMTs) modulate the COVID-19 risk and severity, the efficacy of the COVID-19
vaccines and any impact on MS neurological outcomes given the exclusion of PwMS from COVID-19 vaccine
trials, and the broader consequence of the pandemic on social connection and health outcomes in PwMS.
These gaps create a critical need to rapidly generate rigorous information with which to guide clinical
management. To address these challenges, we created the MSReCOV (MS Resilience to COVID-19)
Collaborative in late March 2020 by assembling a network of MS Centers to leverage existing clinical research
infrastructure and collect patient-reported data. Given the reduced interaction between PwMS and healthcare
systems and the restriction on in-person research activities at the onset and during subsequent phases, we
rapidly deployed online survey studies to gather real-time data directly from PwMS during the pandemic to
complement the effort of physician-reported registries. To complement MSReCOV, we will interrogate the
Optum data warehouse of integrated claims and electronic health records data from a virtual cohort of ~40,000
commercially insured PwMS (per year). Building on the MSReCOV and Optum infrastructure, we propose the
following aims to address the knowledge gaps. Aim 1: Examine the association between MS DMTs and
COVID-19. We will test the hypothesis that certain DMTs such as IFNb are associated with reduced COVID-
19 risk, while others such as B-cell depleting agents are associated with increased COVID-19 risk. Aim 2:
Examine the COVID-19 vaccine efficacy and safety in MS and association with MS outcomes. We will
first test the hypothesis that COVID-19 vaccines are effective and safe in PwMS and do not worsen clinically
relevant patient-reported outcomes (PROs) of neurological function, and secondarily test the hypothesis that B-
cell depleting treatments reduce vaccine efficacy whereas other DMTs do not. Aim 3: Examine the effect of
the pandemic on personal social network and MS outcomes in PwMS. Building on our prior works, we will
test the hypothesis that the pandemic (independent of the SARS-CoV-2 infection) negatively influences the
neurological function in PwMS by altering personal social connection. Given the extent of the COVID-19
pandemic, real-world evidence emerging from the proposed study will critically inform the clinical management
of PwMS during the rapidly changing landscape of neurological care. The project is highly relevant to the
mission of the NIH/NINDS to reduce the burden of neurological diseases such as MS in the setting of the
pandemic.

Public health relevance
PROJECT NARRATIVE. The COVID-19 pandemic due to SARS-CoV-2 infection poses new challenges to the nearly 3 million persons with multiple sclerosis (PwMS) worldwide. The proposed study aims to address salient knowledge gaps in the clinical management of PwMS during the pandemic and its aftermath. First, we will examine the association between MS immune-modulating disease- modifying therapies and COVID-19 risk and severity. Second, we will examine the COVID-19 vaccine efficacy and safety in MS and association with MS outcomes. Third, we will examine the effect of the pandemic on personal social network and health outcomes in PwMS. To pursue these research questions, we will leverage existing collaborations across multiple academic MS centers and a large data warehouse of integrated claims and electronic health records data. Given the protracted COVID-19 pandemic, real-world evidence emerging from the proposed study will critically inform the clinical management of PwMS during the rapidly changing landscape of neurological care.